Racial disparities in shared decision making for patients with acute respiratory failure

PROJECT SUMMARY/ABSTRACT
The care of critically ill patients with acute respiratory failure (ARF) involves life-or-death decisions.
Ideally, intensive care unit (ICU) clinicians should include patients or their families in shared decision making,
which promotes goal-concordant care, reduces psychological distress for both families and clinicians, and
shortens ICU length of stay. However, racial disparities have been documented in all components of shared
decision making and its associated outcomes. In outpatient settings, clinicians treat Black patients differently
from White patients, providing fewer treatment options, less prognostic information, and less emotional support,
and making assumptions about rather than eliciting patient preferences. Racial disparities in shared decision
making are likely to be amplified in the ICU because clinicians often do not have long-standing relationships with
families, and decisions are time-pressured and highly emotional. To promote equitable ICU care, we must fill
two critical knowledge gaps: (1) we do not fully understand how or why ICU clinicians differently engage Black
and White families in shared decision making about ARF, therefore (2) we do not know how to develop a shared
decision making intervention to reduce racial disparities in SDM for patients with ARF.
To address these evidence gaps, I propose three specific aims: (1) Compare how ICU physicians engage
Black and White families of patients with ARF in decision making using mixed methods to analyze existing
transcripts of ICU physician-family meetings; (2) Elicit family and ICU physician experiences with decision
making about ARF through focus groups and interviews to identify ICU physician-level barriers to shared decision
making with Black families; and (3) Use a human-centered design approach that is guided by feedback from
families and ICU physicians to adapt and feasibility test an existing shared decision making intervention
(“Jumpstart”) in order to mitigate racial disparities for patients with ARF and their families. This work addresses
a key NHLBI priority to “better integrate palliative care concepts, such as respect for treatment preferences, in
the management of patients” with acute respiratory failure.
I will be supported by the robust research environment at Duke University and an interdisciplinary team
of dedicated, nationally respected mentors: Drs. Christopher Cox, Kimberly Johnson, Sharron Docherty, and
Meeta Kerlin. At the completion of the proposed project, I will have developed key scientific skills in clinical trials,
health disparities research, mixed methods research, and intervention development. I will also collect preliminary
data necessary for a follow-up R01 Award to conduct a clinical trial of the adapted intervention. In sum, this K23
Award is critical to my career development, and the results will have a substantial public health impact by
promoting equitable shared decision making for patients with acute respiratory failure and their families.

Public health relevance
Project Narrative/Public Health Relevance Patients with severe lung problems (“acute respiratory failure”) who require life support treatments like ventilators often cannot speak for themselves, therefore their families and intensive care unit (ICU) clinicians should ideally work together to make medical decisions on their behalf in a process known as shared decision making. We know from outpatient clinic settings that shared decision making happens less frequently with Black compared to White patients, but this has not been studied in the ICU among patients with acute respiratory failure, therefore no tools currently exist to support ICU clinicians to engage Black families in shared decision making. In this study, we will document the reasons for racial disparities in shared decision making for patients with acute respiratory failure, and we will adapt an existing shared decision making tool to help ICU clinicians better engage Black families in shared decision making about acute respiratory failure.